Training Program in Cellular and Molecular Membrane Biology

The future of biomedical science critically depends on cross-disciplinary technical expertise in
membrane biology. Membrane-localized receptors are the target for nearly all drug-based
therapies. Therefore, scientists with expertise in protein structure-function, electrophysiology,
membrane trafficking, and cell membrane physiology are indispensable. To meet this need, we
have developed the Training Program in Cellular and Molecular Membrane Biology. Now in its
4th decade, our training program provides innovative interdisciplinary training at the molecular,
cell, and systems biology interface at the University of Maryland School of Medicine
(UMSOM). Our central tenet is that cell membranes mediate and integrate the cellular and
molecular response of the cell to the environment and are thus an essential interface between the
cell and its surroundings. The common goal of the participating laboratories is to understand the
various roles membranes play in biological systems, stressing their role at the cellular and
molecular level and their link to human diseases. We emphasize investigations into how cell
function arises from dynamic interactions between membrane proteins and signaling cascades,
especially those that depend on ion flux (i.e., Ca2+ or K+). Trainees are selected based on their
interests, graduate course grades, recommendations, and previous research experience. Accepted
students take specialized upper-level courses in cell and molecular membrane biology, ion
channel biophysics, biostatistics, hypothesis testing, and experimental design. This curriculum
prepares our trainees for independent research in our faculty’s labs. Training program faculty are
well-funded, highly interactive, and devoted to mentoring students studying a broad range of
subjects related to membrane biology. Mentors are selected for their interests, extramural
support, and commitment to mentoring. Trainees and mentors also participate in enrichment
activities, including a student seminar series, an annual retreat, and career development seminars
given by distinguished program alum from academia, government, and industry. The University
of Maryland School of Medicine generously supports this program through faculty salary
contributions, stipends for additional students, and funds for the training program’s regular
activities. We enjoy a strong partnership with other NIGMS-supported programs at the UMSOM,
including the Medical Scientist Training Program and Initiative for Maximizing Student
Development.

Public health relevance
This training program provides financial support for predoctoral students in the multidisciplinary study of biological membranes. Virtually all medications target proteins that reside in cell membranes, yet expertise is split between multiple scientific areas. Therefore, scientific training across fields will result in a better understanding of how to develop and treat human diseases.